Modified cardiac rehabilitation to enhance post-stroke physical and psychosocial function: does despression limit the response?

ABSTRACT
Stroke has remained a leading cause of disability for the past thirty years and the number of people living with
stroke and subsequent economic burden is expected to continue to grow over the next several decades. Chronic
survivors of stroke have substantially reduced levels of aerobic and muscular fitness and, paradoxically, routine
stroke rehabilitation is not delivered at an intensity sufficient to drastically augment aerobic and muscular
capacities. Consequently, there is a critical need to develop comprehensive and appropriately dosed exercise
programs that are scalable and complementary to current stroke rehabilitation practices. Cardiac rehabilitation
is designed to enhance physical capacity via progressive exercise (aerobic and strengthening) and has been
shown to improve physical and psychosocial impairments that are highly prevalent in patients following cardiac
events (e.g., heart attack). Despite the cardiovascular origins of stroke, survivors are not eligible for cardiac
rehabilitation programs. Consequently, survivors of stroke commonly experience a self-perpetuating cycle of
reduced aerobic and muscular capacities, difficulties performing activities of daily living, and impaired
psychosocial function. Experimental modified cardiac rehabilitation programs for stroke have utilized intensive
aerobic exercise to improve aerobic capacity and locomotor function. Yet, despite representing at least one-third
of survivors of stroke, those with post-stroke depression (PSD) have remained largely underrepresented in such
programs. Given the negative effects of PSD on rehabilitation outcomes and the favorable effects of cardiac
rehabilitation programs on physical function and depression, this represents an opportunity to improve our
current approach to stroke rehabilitation. The proposed study directly addresses this gap in the literature by
testing the effects of Physical Capacity training for ChroniC stroke – Building Aerobic capacity and Muscle
Strength (PC3-BAMS), a 12-week modified cardiac rehabilitation program, on physical and psychosocial function
in community-dwelling survivors of stroke with and without PSD. Subjects, with and without PSD, will receive 36
sessions of PC3-BAMS to determine the impact of a comprehensive modified cardiac rehabilitation program on
post-stroke physical capacity and psychosocial function. Specifically, we hypothesize that subjects without PSD
will demonstrate greater improvements in walking capacity as measured by the six-minute walk test and
improvements in psychosocial function, as measured by the Stroke Impact Scale, will be associated with
improvements in walking capacity. The results of this study will provide vital data describing the effects of a
comprehensive modified cardiac rehabilitation program on improving physical and psychosocial function in
survivors of stroke with and without PSD and will inform stakeholders and policymakers on the benefits of such
programs. The findings from this study may help reduce the impact of chronic stroke and PSD on our public
health system and improve the lives of the millions of survivors of stroke, their care partners, and families.

Public health relevance
Narrative Cardiac rehabilitation is the standard-of-care treatment option for patients with cardiovascular disease and has been shown to improve many aspects critical to patient recovery. We believe that individuals who have had a stroke need to be treated similarly. We will study the effects of a comprehensive modified cardiac rehabilitation program to determine if it can improve some of the physical and psychosocial problems common in survivors of stroke with and without depression, thereby improving quality of life for these individuals and their families.